Feasibility of a New Methodology for Dental Education in Temporomandibular Disorders through Virtual Patient-Based Learning

PROJECT SUMMARY/ABSTRACT
Temporomandibular disorders (TMD) involve pain and dysfunction in the masticatory muscles,
temporomandibular joint, and associated structures, affecting about 30% of the population. Despite its
prevalence, effective TMD management faces challenges due to a limited understanding among dental
professionals which derives from inadequate education during their training. The establishment of Orofacial Pain
as a new dental specialty in 2020 prompted the inclusion of TMD education in predoctoral dental programs
across US dental schools from July 2022. However, the extent of TMD education varies significantly in terms of
content and expertise of faculty delivering the teaching. Moreover, due to the limited number of orofacial pain
specialists within predoctoral dental schools, many TMD patients are referred elsewhere for treatment or
considered outside the scope of the university, leaving dental students with insufficient clinical exposure to TMD
cases during their training. Given these gaps in knowledge with the present modalities of education and the
limited clinical exposure to TMD cases offered by most predoctoral dental institutions to their students, there is
a critical need to explore new educational methodologies to overcome these issues. The proposed project aims
to address these critical gaps by developing and testing a virtual patient-based learning (VPBL) methodology,
incorporating real patient data into interactive clinical scenarios and integrating it in the TMD curriculum of a
predoctoral dental school lacking an orofacial pain program. The appropriateness and comprehensiveness of
the virtual patient clinical scenarios will be reviewed and tested by experts in the field (Aim 1). Subsequently, the
feasibility and utility of this new technological and educational methodology will be assessed among third- and
fourth-year dental students at a predoctoral dental school with a REDCap questionnaire (Aim 2). The central
hypothesis is that digital learning integrated into the predoctoral TMD curriculum will demonstrate high levels of
feasibility, acceptability, usefulness, and applicability for clinical reasoning. The overarching goal of this program
is to improve quality of care for underserved TMD patients by equipping future dental providers with the
necessary skills to diagnose and manage TMD conditions effectively. Implementing VPBL offers a promising
solution to bridge the gaps in dental education and the limited clinical exposure to TMD cases during predoctoral
training. The findings of the proposed project will inform about the feasibility and utility of integrating this
innovative technology into dental education. Following a successful randomized clinical trial, a future R01 grant
will explore the full potential of this program through Dissemination and Implementation (D&I) strategies. By
disseminating the VPBL platform to dental institutions across the nation and integrating it into curricula, the
proposed project aims to fill important gaps in knowledge of future dental professionals and improve treatment
to an underserved population. By doing so, it aims to advance dental education while promoting innovative
approaches.

Public health relevance
PROJECT NARRATIVE This research project proposes to develop and pilot a virtual patient-based learning platform to be integrated in a predoctoral dental school with limited clinical exposure to TMD patients, by merging real patient data into interactive clinical scenarios. The goal is to address gaps in knowledge in dental education and the limited clinical opportunities to TMD cases during predoctoral training, ultimately improving patient care and advancing healthcare education.